The Role of Social Supports in Mitigating the Effects of Adverse Childhood Experiences on Adolescent Psychopathology

Project Summary
Over 61% of adults surveyed in 2017 across 23 states experienced at least one type of adverse childhood event
(ACE). Black, Indigenous, and other Youth Of Color (BIYOC) are more likely to report having experienced four
or more types of ACEs than their White counterparts, rendering it even more critical to understand the culturally
specific protective mechanisms that buffer the negative impact of ACEs. Despite exposures to ACEs, at-risk
youth still thrive; though a clear understanding of the underlying conditions that build resilience remains widely
unknown, particularly for BIYOC youth. While the past 20 years of research has also shed light on the toll ACEs
has on adolescent psychopathology, most findings to date: (1) do not include samples from racially diverse
populations, (2) disproportionately focus on adult populations, and (3) do not capture an adequate number of
data collection timepoints from early to late adolescence. The Adolescent Brain Cognitive Development study
started collecting data on social, behavioral, physical, and environmental factors that may affect health outcomes
in 2016, when youth (N=11,874) were between 9-10 years of age. This socio-demographically diverse national
study of 21 research sites across the U.S. entails collecting data for 10 years, until 2026. Utilizing these data,
we aim to examine the following: 1) prevalence of ACEs among BIYOC, 2) BIYOC's long-term impact of ACEs
on internalizing/externalizing behaviors from early to late adolescence, and 3) whether social supports
(caregiver, peer, neighborhood) buffer the long-term effects of exposures to ACEs on behavior. We will analyze
longitudinal data from BIYOC to identify the critical junctures by which trauma and social support impact
behavioral functioning. Relying upon a cross-lagged analytic approach, we will generate an empirical model
elucidating the extent to which social supports influence the long-term effects of exposures to ACEs on behaviors
among BIYOC. Results will identify how to cultivate and make accessible the specific types of social support that
mitigate the effects of ACEs.

Public health relevance
Project Narrative With public health experts warning us of the increasing prevalence of adolescent mental health problems, it is of critical importance to understand the effects of social supports on mitigating the effects of trauma, particularly for minoritized youth, whose experiences are less understood. By following the same cohort of socio- demographically diverse adolescents in the longitudinal Adolescent Brain Cognitive Development study, we will identify the critical junctures by which trauma and social support impact behavioral functioning. Findings will lend guidance on how to make accessible the specific types of culturally relevant social supports that minimize symptoms of externalizing and internalizing behaviors due to adverse childhood experiences.